BLRD Research Career Scientist Award Application

The overarching goal of my research program is to understand tissue specific immunity with focus on the lungs.
Immune cells continuously surveil the lungs to respond quickly to infections. Mycobacterium tuberculosis (Mtb)
causes chronic tuberculosis (TB) and Francisella tularensis causes acute tularemia—two bacteria that cause
respiratory infectious diseases. I have developed two large-scale T cell epitope discovery programs that leverage
our strengths and my forte: the Merit supports the Mtb program; and AI137982 “Molecular Basis of CD1D and
Natural Killer T Cell Function”, awarded in August 2019, after the RCS began, supports F. tularensis research.
New support has been sought via a response to an RFA BAA-NIAID-DAIT-75N93022R00023: “FUNCTIONAL
IMMUNOPEPTIDOMICS: Large-Scale F tularensis-derived Epitope Discovery & Correlates of T Cell Immunity”.
Our Mtb work addresses a critical unmet need for an effective vaccine against TB that will significantly
improve the quality of life of our Veterans. Mtb lives and multiplies within the host immune cell called
macrophages, which are voracious eaters of bacteria and other foreign substances. Mtb has evolved ways to
prevent macrophages from doing so, making life within infected cells possible. To get rid of the infection, the
host needs to engage the killer cells of the immune system, one such killer cell is called CD8+ T cell. CD8+ T
cells are equipped to find infected cells in very specific manner when antigens are presented in association with
the hosts’ Human Leukocyte Antigen (HLA)-I molecule. HLA-I are different between individuals making T cell
vaccine development difficult. Fortunately, HLA-I can be grouped into nine supertypes—B7 is one such
supertype expressed by 40—45% of the human population. Once specific antigen recognition occurs, these
effector cells deploy killing mechanisms to destroy the infected cells, leaving no place for the bacteria to live.
Hence, the overarching goal of the Merit research is to develop a vaccine platform against TB that harnesses
CD8+ T cell functions. This program leverages 30+ years of my experience in the field of antigen processing and
presentation to T cells. Thus, in a systematic approach to vaccine design, our work involves pre-clinical studies
that aims to identify MTb-derived antigens expressed only by infected macrophages so that CD8+ T cells can
recognize such antigens, kill infected cells, and, thereby, confer protection to the host. In addition to vaccine
design, our research will develop platforms for the delivery of next generation TB vaccines directly to the site of
Mtb infection which is the lungs. We have made great strides toward both these goals: To facilitate the antigen
discovery goal, we have developed new HLA-I transgenic humanized mouse lines. Then in a high-throughput
antigen presentation assay that leverages a novel ultrahigh-density peptide arrays, we discovered 100s of
peptide antigens that are presented by four common human MHC molecules. By bioinformatics approach we
have winnowed down to 35 most likely MTb antigens recognized by CD8+ T cells, of which several are
immunogenic Mtb-derived peptides and presented by members of the B7 supertype. Candidate antigens in these
novel humanized mouse models are at the centre of the current investigations. Toward the development of
platforms for vaccine delivery to the lungs—we have designed and validated nanoparticle platforms adjuvanted
with three different chemicals that activate the innate immune system. The unique feature of these platforms is
the ability to target the nanoparticle to the cytosol of a host immune cell called dendritic cell (DC), which are
critical for antigen presentation to CD8+ T cells. We will harness this delivery platform to deliver the antigen/s
discovered in the discovery phase of the project summarized above, tether the nanoparticle with an adjuvant to
activate DCs, for delivery to the lungs. In summary, this pre-clinical, translational project is on an upward
trajectory and will validate the ‘discover & deliver’ platform for a vaccine against TB. Success with this project
brings with it the promise of delivering better health care to our Veterans, especially the downtrodden amongst
them and, hence, the most burdened by the scourge of tuberculosis.

Public health relevance
Our Veterans have become susceptible to infections with Mycobacterium tuberculosis—the agent of a chronic infectious disease called tuberculosis (TB). TB causes high morbidity and mortality. The global burden of TB continues to increase with the emergence of multidrug-resistant and extremely drug resistant M tuberculosis strains, and the lack of an effective vaccine that protects adults from mycobacterial infection and TB disease. The current application seeks support to develop an effective and durable vaccine that can protect our Veterans. As M tuberculosis is transmitted through aerosols and infects the lung mucosa, the challenge is to install immune effector cells at the site of infection. Our research group has developed ways to install pathogen-specific immune effectors in the lungs, which is the major route of mycobacterial infection. Using the new insights, we will develop and test a durable vaccine against TB in a preclinical animal model. This work will lead to the design of novel vaccine strategies against TB and enhance the quality of care of our Veterans’ health.